Developing, Demonstrating, and Disseminating Innovative Programs to Achieve Translational Success

The overall vision of the Rockefeller University Center for Clinical and Translational
Science (CCTS), supported by the CTSA program, is to develop, demonstrate, and disseminate
innovative programs so as to create a model clinical research enterprise built on rigor,
responsible and transparent reporting, and scientific integrity to empower translation of
paradigm-breaking discoveries into better human health. Our new initiatives are designed to: 1)
ensure that all of our studies set the highest standards; 2) ensure that our trainees have the team
science leadership skills needed for a career in translational science; and 3) enhance
scientific rigor, reproducibility, and reporting. These new areas build on the
infrastructure we have developed to integrate mechanistic science into community engagement,
reach out to basic scientists, speed the development of health- enhancing products, and create an
optimal training environment. Our specific aims are: 1. To provide a robust infrastructure to
support the conduct of clinical investigation at the highest levels of participant safety,
scientific rigor, bioethics, and regulatory compliance. We will enhance our multidisciplinary
Translational Research Navigation (TRN) Program and our collaboration with Clinical Directors
Network (CDN), a Practice Based Research Network of Community Health Centers, to ensure that our
studies meet the highest standards of design, feasibility, method validity, and transparent
reporting, supporting our active participation in the CTSA Trial Innovation Network. 2. To ensure
that every discovery at Rockefeller has the best chance of improving human health. We will enhance
our robust pipeline of programs to support basic and clinical investigators move their
paradigm-breaking discoveries into new therapeutics by leveraging the resources of the
Tri-Institutional Therapeutic Development Institute, the Robertson Therapeutic Development Fund,
and the University affiliated biotechnology company, Bridge Medicines .3. To educate the entire
research workforce team in conducting translational research at the highest levels of participant
safety, scientific rigor, bioethics, and regulatory compliance. We will further enhance the
multidisciplinary team science emphasis of our educational programs for KL2 Clinical Scholars,
Clinical Research Nurses, basic scientists, and community clinicians, with a focus on our new
Team Science Leadership training with the CTSA Hubs at Yale, University of
Pennsylvania, and Columbia. 4. To study and improve the clinical research enterprise both at
Rockefeller and nationally. We will continue to use the CCTS as a laboratory for investigating the
clinical research enterprise itself and methods to improve it, including obtaining outcome data
from research participants, enhancing rigor, reproducibility and reporting, speeding the evaluation
of novel therapeutics via in-house formulation, and creating 'super teams' of CTSA Hubs to
disseminate our model of community engagement harnessing basic mechanistic studies to
address community-identified health needs. We will disseminate the results throughout the CTSA
consortium and scientific community by publications, presentations, and active participation in
CLIC and CD2H initiatives.

Public health relevance
The Rockefeller University Center for Clinical and Translational Science is dedicated to improving human health by providing resources and personnel to support the conduct of the highest quality research to improve the prevention, diagnosis, and treatment of human disease. It will also produce novel methods to improve both the scientific information obtained in the studies and the way in which the research is performed.